CYTOKINES IN HUMAN INTRAOCULAR FLUIDS

The relationship of intraocular cytokines to human retinal detachment and proliferative vitreoretinopathy (PVR) was explored in 1988 by directly assaying human specimens for the presence of interleukin 1 (IL-1) and interleukin 2 (IL-2). In 1989, we expanded the project to include a rabbit model of PVR. The intraocular fluids of 18 rabbits in three treatment groups were assayed for the presence of IL-1, IL-2, and transforming growth factor beta (TGF-beta) at various times during the course of PVR. No definite pattern of IL-1 activity was detected; however, both TGF-beta and IL-2 activity appeared to follow a time course related to stage of disease. Increased IL-2 activity was noted in eyes with PVR beginning 3 weeks after induction of the disease. Increased levels of active TGF-beta were noted at about the same time in PVR eyes. These preliminary findings support a physiological role of TGF-beta in PVR and also suggest that a different cytokine with IL-2 activity is involved in the cellular proliferative processes of PVR.